Developing Deterministic Computational Models and Statistical Analysis of VEGF+PDGF Cross-Family Signaling in Adipose Tissue

PROJECT SUMMARY/ABSTRACT
The vascular endothelial growth factors (VEGFs) direct key signaling processes in obesity and at least 70 other diseases.
However, focus on this signaling node alone has not achieved the promise of predictable angiogenic control. Current models
are incomplete as other growth factors, besides VEGF, contribute to vascular disease progression, presenting a complexity
that cannot be predictably regulated by targeting one node in this system. Therefore, there is a continuing need to account
for the complexity of additional, multi-component signaling networks, a goal that can be achieved via data-driven,
computational systems biology in close concert with experimental analysis of signaling and functional response.
Toward this goal, we aim to examine a novel paradigm of network regulation called cross-family signaling, in which
members from one growth factor family [e.g., platelet derived growth factors (PDGFs)] bind to and signal through members
of another family (e.g., VEGFRs). We hypothesize that systematic examination of protein structure and downstream
signaling within the cross-family paradigm via simulation, ligand-engineering, network quantification, and computational
modeling can uncover novel mechanisms to control angiogenesis. We will test this hypothesis through three aims,
sensitively quantifying receptor activation rates and functional responses of cross-family binding (e.g., proliferation,
migration, and barrier function); predicting and measuring the structural properties of cross-family binding via molecular
simulations and directed evolution; and developing validated deterministic models (mass-action kinetic modeling) of cross-
family signaling and applying them to study and control the dynamics of cross-family signaling in human cell systems, in
silico.
We are primed to lead this new research because we are among the first to pursue this important theoretical paradigm, and
we lead this cause to understand cell signaling via structure/function–based computational modeling. This work will
catalyze a shift in perspective and innovation in the areas of cell signaling, systems biology, and predictive design of obesity-
focused therapies.

Public health relevance
PROJECT NARRATIVE Angiogenesis is a key pathogenic component of obesity and at least 70 known diseases, and it is primarily driven by the vascular endothelial growth factor receptor (VEGFR) and its family of VEGF ligands. However, targeting VEGF alone has not achieved the promise of stable vascular control, so new approaches are needed to control and direct vascular development. The purpose of these studies is to biologically and computationally assess how the new theory of cross- family signaling may control vascular signaling at the molecular, protein, and cellular levels.